2023 Woods Hole Immunoparasitology Meeting

This application for funding is to support expenses for the 2023 26th Annual Woods Hole
Immunoparasitology Meeting (WHIP), which brings together principal investigators, students and
postdoctoral fellows from around the world who are in the field of immunoparasitology. The 2023
meeting will be held on April 23-26, 2023 as an in-person meeting with virtual components. The annual
gathering of scholars in this field was established in 1997 with the intent to provide a collegial meeting
place for scientists to exchange ideas in this important field. Due to the pandemic the meeting developed
a hybrid format this last year and had a total of 151 attendees. While there are other meetings where
senior principal investigators in this field present their data, the focus of this meeting is to provide a forum
where graduate students and postdoctoral fellows present their work to each other and established
investigators. The meeting also aims to provide the opportunity to highlight new junior faculty in the field.
The location was chosen because of the strong association of the Marine Biology Laboratory (MBL) and
the field of parasitology. This relationship began almost 40 years ago with the establishment of the
annual summer course, “Biology of Parasitism,” and with the annual Molecular Parasitology meeting held
in the fall at the MBL. It is close to laboratories on the east coast, and accessible via direct flights to
Boston from around the world. Over 85% of the talks at the WHIP meeting will be given by either
graduate students or post-doctoral fellows, making this a unique meeting in the field. In addition to the
oral presentations, all of the students and post-doctoral fellows have the opportunity to present their work
in poster sessions. Thus, both in oral talks and poster sessions students and post-doctoral fellows in the
field of immunoparasitology gain valuable experience in presenting their data, as well as contacts that
will be useful for advancing their science and their careers.

Public health relevance
The Woods Hole Immunoparasitology Meeting (WHIP) brings together scientists who study many neglected tropical diseases of the world, and the parasitic diseases endemic in the United States. The exchange of information and ideas that occur at this meeting will advance the development of new treatments for these diseases.